Do Transfemoral Prostheses with Powered Prosthetic Knee Flexion and Extension Improve Mobility? A Biomechanical Evaluation of the Ossur Power Knee

The anatomical knee is a complex, polycentric joint characterized by a large range of motion in the sagittal plane
and limited mobility in the coronal and transverse planes (1). The sagittal plane motion is used for progression
in stance phase, and limb clearance and advancement in swing (2). Limb prostheses are intended to restore
function and cosmesis in persons with limb loss. The complexity and function of prosthetic components have
advanced significantly as technology has improved, but a state-of-the-art artificial limb is still a relatively poor
substitute for an anatomical one. Microprocessor-controlled knees (MPKs) do not typically utilize motors to power
joint rotation, but they automatically adjust resistance or damping in the joint to improve swing- and/or stance-
phase control as appropriate for the user during gait. The Ossur Power Knee (6-9), which was first introduced in
2006, is the only MPK that uses a motor to provide active power generation during walking and other activities
involving knee flexion and extension. Last year, Ossur released the 3rd generation of its Power Knee and
appears to have addressed many of the previous shortcomings in terms of reduced weight, less noise, lower
cost and longer battery life. Therefore, we believe that the newest version of the Power Knee warrants a fresh
evaluation since it is, in essence, substantially different in design and function from previous models.
The purpose of this proposed investigation is to perform biomechanical evaluations of the new Ossur Power
Knee during walking and other activities by transfemoral prosthesis users. Using a cross-over experimental
design, approximately 20 unilateral, transfemoral amputee subjects (10 men and 10 women) will be evaluated
in the Jesse Brown VAMC Motion Analysis Research Laboratory (MARL) while wearing the Ossur Power Knee
and Ossur Rheo XC, which is a passive MPK device. Furthermore, we believe that the Ossur Power Knee may
offer distinct advantages to female prosthesis users, so we intend to compare mobility between men and women
to determine if differences exist on the basis of sex. The specific aims and hypotheses of this project are:
Aim 1: To compare the effects of the Ossur Power Knee and Ossur Rheo XC on the gait of unilateral,
transfemoral prosthesis users during level walking. Kinematic and kinetic data will be collected as
subjects walk in the MARL. We hypothesize that the active knee flexion and extension provided by
the Ossur Power Knee will (1) improve walking performance, and (2) reduce metabolic energy cost
during ambulation.
Aim 2: To compare the effects of the Ossur Power Knee and Ossur Rheo XC on stairs, slopes and during
sit-to-stand/stand-to-sit activities of unilateral, transfemoral prosthesis users. Kinematic data will be
collected as subjects perform these activities. We hypothesize that subjects will have improved
performance when using the Ossur Power Knee.
Aim 3: To analyze and compare gender specific data between subjects using the Ossur Power Knee and
the Ossur Rheo XC. We hypothesize that male and female subjects will demonstrate substantially
different abilities to use the two knee components, indicating that gender specific components should
be further investigated and developed. Research focusing on the unique prosthetic needs of women
Veterans is currently a special emphasis area of the VA RR&D Service.
Subjects will also be administered questionnaires and provided at-home diaries to document their perceptions
of comfort, exertion and stability while using the different prosthetic knee units. Increased understanding about
how the Ossur Power Knee affects the abilities of transfemoral prosthesis users will facilitate appropriate
component selection by prosthetists and ultimately improve quality of life for prosthesis users.

Public health relevance
Microprocessor-controlled knees (MPKs) do not typically utilize motors to power joint rotation, but they automatically adjust resistance or damping in the joint to improve swing- and/or stance-phase control as appropriate for the prosthesis user during gait. The Ossur Power Knee is the only commercially-available MPK that uses a motor to provide active power generation during walking and other activities. The purpose of this proposed investigation is to perform and compare biomechanical evaluations of the Power Knee and Ossur Rheo XC, a passive MPK, during walking and other activities by prosthesis users. Furthermore, we will compare mobility between male and female subjects to determine if there are differences in prosthetic knee usage on the basis of sex. The Veterans Health Administration (VHA) reported that between 1989-1998, 29% of amputations were performed at the transfemoral level. This emphasizes the strong relevance and potentially high impact of this research study on current Veterans, which is directly applicable to the VHA’s Patient Care Mission.